Genetic Contributors to the Impact of Sex on Heterogeneity in Flu Infection

The 1918 influenza pandemic is estimated to have killed 1 in 20 people worldwide. Influenza A virus (IAV)
infections usually do not cause such severe disease for the ~30 million infected every year in the United States
alone (2014-2015). However, there are broad differences in IAV susceptibility and severity, with outcomes from
asymptomatic infections (~16%) to death (0.2% in 2014-2015). These differences arise from the complex
interplay of exposure, environment, IAV genetics, and host factors. A crucial host factor that contributes to
heterogeneity of IAV infection is biological sex. For children and older individuals, males are more likely to
experience severe disease, while females of child-bearing age have greater severity. We hypothesize that sex
differences in gene expression are a major driver of heterogeneity in IAV infection. In the parent award, we are
identifying sex-specific differences in gene expression that regulate IAV burden and host response in human
cells, IAV challenge volunteers, and natural populations. In this Supplement, we propose to use two Common
Fund resources to expand the biological understanding of sex differences during IAV infection that will be
revealed from this study and to determine the generalizability of our findings across all human tissues.
In the first supplement Aim, we will use LINCS to understand sex differences in the response to IAV
infection in cells and human volunteers. The LINCS signatures database, as implemented in the iLINCS
portal, will be leveraged to identify the critical genes that drive male- or female-biased gene expression following
IAV infection. Specifically, querying the LINCS CGS (consensus gene knockdown signatures) and LINCS gene
overexpression signatures will reveal genes that when knocked down or overexpressed mimic signatures
observed in male and female lymphoblastoid cell lines (LCLs) and volunteers following IAV infection. Such
signatures may reveal signaling pathways that could explain some of the sex differences seen during IAV
infection in cells and humans. Further, LINCS analysis using chemical perturbagen signatures will reveal small
molecule reversers and mimickers of the gene expression changes that will serve as starting points for
pharmacological targeting to improve outcomes in severe flu infection. In the second supplement Aim, we will
use GTEx to determine the generalizability of sex-biased genes and expression quantitative trait loci (sb-
Genes and sb-eQTLs) during IAV infection across human tissues. In the parent grant, we are identifying sb-
Genes and sb-eQTLs in IAV-infected LCLs and in whole blood and nasal curettage from human challenge
volunteers. We will use GTEx to determine whether sb-Genes and sb-eQTLs identified in IAV-infected LCLs and
whole blood from human volunteers are applicable to other tissues, increasing the generalizability of our findings.
This Supplement Application proposes to utilize two Common Fund Resources, LINCS and GTEx, to increase
the insight and generalizability of the parent award. Doing so will increase our understanding of the genetic basis
for sex differences and could lead to novel therapeutic strategies.

Public health relevance
Project Narrative Influenza causes millions of respiratory infections every year, but there are substantial differences in the susceptibility of each person to severe flu infection. Sex differences are a major contributor to this variation. In this Supplement, we propose to use two NIH Common Fund resources to expand the biological understanding of sex differences during influenza A virus infection and to determine the generalizability of our findings across all human tissues. This research will increase our understanding of why the flu can be so different among people and could lead to novel therapeutic strategies.